Developing Purkinje Cell Synaptic Therapies to Restore Circuit Function in Cerebellar Degeneration

PROJECT SUMMARY/ ABSTRACT
Individuals with cerebellar degeneration suffer from incapacitating ataxia symptoms, such as imbalance,
frequent falls, and loss of movement control. Regrettably, no existing therapies are available to treat ataxia
symptoms, partly due to an incomplete understanding of the brain circuit alterations responsible for these
symptoms, resulting in many patients being left disabled. Prior research in animal models and postmortem
human brains have elucidated a defined sequence of cerebellar degeneration: Purkinje cells (PCs), the
principal neurons of the cerebellar circuit, initially prune their excitatory synapses, including climbing fiber (CF)-
PC synapses, in the early stage of degeneration, followed by subsequent PC loss in the late stage of
degeneration. Therefore, targeting these circuit changes in a stage-specific manner holds promise for restoring
circuit function in cerebellar degeneration. Our preliminary data showed that inhibition of CF-PC synaptic
activity directly induces ataxia-like behaviors and disrupts cerebellar physiology, specifically reducing the
cerebellar alpha rhythm (8-13Hz) in mice. CF-PC synaptic interventions thus have the potential to restore
circuit function, and cerebellar alpha rhythm may serve as a means to monitor circuit function. However, before
progressing to clinical trials for synaptic therapies, knowledge gaps still exist: 1) Does CF-PC synaptic
intervention improve ataxia symptoms? 2) Are the effects of the intervention different in the early vs. late
stages of degeneration? 3) Does cerebellar alpha rhythm track stages of degeneration in vivo and reflect
therapeutic responses? To address these questions, we propose testing the hypothesis that loss of CF-PC
synapses differentially contributes to disturbed cerebellar physiology and ataxia symptoms in early vs. late
stages of cerebellar degeneration. In this proposal, we will study a mouse model of cerebellar degeneration
and determine the anatomical basis of reduced cerebellar alpha rhythm in early vs. late stages of degeneration
to validate the future use of cerebellar alpha rhythm to monitor circuit function (Aim 1). We will assess if
enhancing the activity of remaining CF-PC synapses can be a therapeutic strategy to improve the cerebellar
alpha rhythm and ataxia symptoms in early vs. late stages of degeneration (Aim 2). Finally, we will examine
another therapeutic approach and determine if promoting new CF-PC synapses improves the cerebellar alpha
rhythm and ataxia symptoms in early vs. late stages of degeneration (Aim 3). The knowledge gained from this
research will provide insights for developing disease-stage-specific therapies to restore circuit function in
cerebellar degeneration.

Public health relevance
PROJECT NARRATIVE Neurodegeneration of the cerebellum results in disabling ataxia symptoms, including imbalance, frequent falls, and loss of movement control. Currently, no therapies are available to treat these ataxia symptoms, primarily due to a limited understanding of the brain circuit alterations responsible for these symptoms. The proposed research aims to test therapeutic strategies for restoring brain circuit function, and the knowledge gained will serve as a foundation for developing therapies for cerebellar degeneration.